The Impact of Local and Reversible Change to GABAergic Inhibitory Signaling on Tumor-Induced Cortical Dysfunction in Glioma

PROJECT SUMMARY
Tumor-associated seizures and focal neurological deficits are a major source of morbidity in patients with
diffusely infiltrating glioma. Tumor-associated seizures are difficult to treat, and patients with diffusely infiltrating
glioma often experience recurrent seizures despite treatment with multiple anticonvulsant drugs. Tumor-induced
neurological deficits can be equally debilitating and are associated with decreased quality of life, reduced
functional independence, and decreased survival. Thus, targeted therapy to address these symptoms is of great
clinical significance and remains an unmet need in patients with diffusely infiltrating glioma. Using a mouse model
of tumor-associated seizures, we showed that cortical hyper-excitability and seizures are associated with loss of
inhibitory GABAergic signaling. Our published work and preliminary data demonstrate that acute treatment with
the mTOR inhibitor AZD8055 1. Reduces tumor-associated seizures 2. Restores normal excitatory neuron
stimulus-triggered responses to physiologic stimulation in a model of tumor-induced neurological deficits. and 3.
Restores local inhibitory GABAergic signaling - through its effects on GABAergic interneuron firing and the
GABA-A reversal potential of excitatory neurons - thereby providing a potential mechanism for its anticonvulsant
effects and pointing to potential synergistic effects of combining AZD8055 with GABAergic drugs as a new
therapeutic strategy. Here we propose to mechanistically link and leverage these inter-related findings and test
the hypothesis that tumor-induced alterations in peritumoral neuronal mTOR and GABAergic signaling
mechanistically contribute to both tumor-associated seizures and focal neurological deficits and thus represent
synergistic targets for tumor-induced neurological dysfunction. We will test this in 3 aims: In Aim 1, we will test
whether mTOR-dependent alterations in GABAergic signaling are necessary to decrease tumor-associated
seizures. In this aim we will also use systemic and local delivery to test the anticonvulsant effects of AZD8055
and the GABA transaminase inhibitor vigabatrin. In Aim 2, we will test whether mTOR-dependent alterations in
GABAergic signaling are necessary to restore local cortical function and restore neurological deficits. In Aim 3,
we will determine the effect of mTOR inhibition on the electrophysiologic properties and expression profiles of
peritumoral neurons in human glioma.

Public health relevance
PROJECT NARRATIVE Tumor-associated seizures and neurological deficits are major sources of morbidity in patients with glioma, and targeted brain tumor-specific therapies are urgently needed to address and ameliorate these symptoms. Our preliminary studies point to tumor-induced alterations in local inhibitory GABAergic signaling as a central mechanism for both tumor-associated seizures and tumor-induced neurological deficits and we have identified a role for mTOR inhibition in reversing these changes. In this proposal we will extend this work and determine whether mTOR inhibitors can be combined with GABAergic agonists to ameliorate tumor-induced neurological dysfunction.